Biostatistics for Research in Genomics and Cancer

Project Summary
This 5 year program is designed to continue to train predoctoral (PhD) students in statistical
genomics with the major emphasis in cancer genomics. The goal is to train biostatisticians in
the biology, etiology, and genetics of cancer, as well as to train them to conduct state-of-the-art
biostatistical methodologic research relevant to the genomics of cancer as well as in related
areas of genomics. The goal is to also produce biostatisticians who can collaborate with other
scientific researchers and oncologists on research issues related to genomics and cancer. The
typical predoctoral trainee will be a college graduate or master's level graduate with an excellent
academic record appropriate for this training area. Funding is requested for the support of 5
predoctoral trainees. The Department of Biostatistics at UNC is one of the largest in the world,
and has highly qualified personnel and the available facilities to provide the most
comprehensive predoctoral and postdoctoral training in this research area. Several members
from the Department of Genetics and the Bioinformatics and Computational Biology (BCB)
program will be deeply involved in all phases of this training program and will play an integral
role in this training program.

Public health relevance
Narrative This training grant clearly has major relevance in public health as it is designed to train the next wave of biostatistical researchers in cancer genomics, which is one of the largest and growing areas of biomedical research, in which the demand for well trained biostatistical researchers is much greater than the supply.